Temporal profiling of corticospinal motor neurons reveals novel therapeutic targets for spinal cord injury

PROJECT SUMMARY More than 100 years of research has shown that the adult central nervous system is incapable of self-repair after injury or disease. Indeed, adults that suffer traumatic spinal cord injuries maintain chronic functional deficits that impact all aspects of their lives. However, increasing evidence suggests that the adult CNS retains the ability to initiate a growth program and functionally re-organize in response to activity, experience and mild trauma. To identify the molecular machinery driving this growth response we completed an unbiased in vivo transcriptomic screen of corticospinal motor neuron during the entire temporally defined course of normal corticospinal tract growth and wiring. We believe that a comprehensive understanding of the transcriptomic signature that underlies all phases of corticospinal tract growth, from outgrowth through axon elongation, pathfinding, target recognition and synapse formation, will guide refined therapeutic intervention to functionally repair the acutely and chronically damaged spinal cord.

Public health relevance
NARRATIVE There are no effective treatments for spinal cord injury (SCI). The financial and emotional burden these injuries have on patients and their families highlights the urgent clinical need for potent and effective repair strategies. The aim of this proposal is to define the molecular machinery that drives normal growth and patterning of the corticospinal tract and determine whether this intrinsically mediated axon growth program can be exploited to more comprehensively restore function after severe acute and chronic SCI.